Biomedical Research and Education Training Program

SUMMARY/ABSTRACT
This application seeks a one-year Supplement to the INSPIRE IRACDA Postdoctoral Training
Program that began at Robert Wood Johnson Medical School (RWJMS) in August of 2010.
RWJMS is now part of Rutgers University, creating an expanded pool of postdoctoral fellows and
laboratories for the INSPIRE Program. INSPIRE would like to build on its accomplishments during
the first 11 years to further address its two goals: (1) to train the next generation of scientist-
educators by creating an innovative postdoctoral training model and (2) to encourage
undergraduates underrepresented in research to consider careers in biomedical sciences. The
success of INSPIRE is evident in that (1) 68% of INSPIRE Fellows have obtained academic
positions after research training at Rutgers laboratories and mentored teaching at our partner
institutions, Medgar Evers College – CUNY and New Jersey City University, two institutions that
successfully educate groups underrepresented in biomedical research; and (2) INSPIRE has
promoted improved science courses, Scientific Teaching training by partner school faculty,
increased research experiences for the undergraduates at partner schools, increased research
interactions between Rutgers and the partner schools, and has directly led to undergraduates at
these schools becoming aware of and applying to graduate programs in STEM. To increase the
impact of the INSPIRE Program a third partner school was added, William Paterson University
(WPU), a public institution committed to advancing science education for underrepresented
students, and with a former IRACDA Fellow on its faculty, who serves as Campus Coordinator.
The proposed INSPIRE program will continue to be a structured 3-year postdoctoral training
program for 4 trainees per year, i.e., reaching a total of 12 trainees. Continuing its original,
successful training plan, the trainees will participate in mentored research in Rutgers laboratories;
a structured career development program; a structured educational component including an
intensive semester-long workshop in scientific teaching during year 1; and mentored teaching and
course development at partner schools during years 2 and 3. Interaction of partner school faculty
with faculty and postdoctoral trainees at a research-intensive university, and active participation
of the postdoctoral trainees in teaching and mentoring undergraduates will continue to enhance
the students' scientific development and awareness of scientific career pathways. This program
will be evaluated by measuring (a) undergraduate student application and entry into mentored
research programs and awareness of research careers; (b) curriculum development at partner
schools of 4 science courses to increase student engagement in STEM courses; (c) increased
research collaborations between Rutgers and its partner schools facilitated by new funds to bring
25 partner school undergraduates to Rutgers for research and (d) entry of 70% of INSPIRE
postdocs, including underrepresented trainees, into academic tenure track education/research
careers.

Public health relevance
Project Narrative The one-year Supplement to the INSPIRE - IRACDA Postdoctoral Training Program will support the training opportunities for INSPIRE Fellows, postdoctoral fellows who will be prepared to excel as the next generation of scientist- educators. INSPIRE postdoctoral training in research and education will be provided at Rutgers University, a public institution that trains over 500 postdoctoral fellows each year. Finally and most importantly, this Training Program will support the education and research environment at three public institutions, Medgar Evers College – CUNY, New Jersey City University, NJ, and William Paterson University, NJ, that have a demonstrated commitment to educating undergraduate students from groups underrepresented in biomedical research careers.